Advancing Non-Abstinence Outcomes in the Treatment of Methamphetamine Use Disorder

ABSTRACT
This project will provide critical evidence to advance multiple non-abstinence endpoints through the conduct
of a clinical trial that will evaluate how reduced methamphetamine use impacts a diverse range of outcomes in
individuals seeking treatment for Methamphetamine Use Disorder (MUD). The rise in MUD is a growing public
health concern with rates of methamphetamine-associated overdose greatly increasing, especially in
underserved populations, made worse by a lack of approved or implemented MUD interventions.
Methamphetamine use is associated with a range of health concerns that can be non-abstinence treatment
targets but that have yet to be prospectively evaluated in clinical trials. This trial seeks to determine whether
reduced methamphetamine use improves outcomes like cardiovascular health, immune function, sleep quality
and other measures related to psychosocial function. We propose a randomized, controlled 12-week trial using
incentives to reduce methamphetamine use, with an additional 12 weeks of follow up. We will randomly assign
treatment seeking subjects with MUD to one of two groups (1:1; n=100/group): 1) incentives for providing one
or fewer methamphetamine positive urine samples per week in the trial, in which frequency of use is expected
to be substantially reduced or 2) a non-contingent control group, in which frequency of use is expected to
remain stable. We will assess improvements in selected outcomes using validated self-report items and
objective measures, including blood biomarkers. This research will fill a critical knowledge gap with impactful
data about the biomedical and psychosocial benefits of reduced methamphetamine use, which can then be
used to advance non-abstinence outcomes as treatment indicators for MUD trials.

Public health relevance
PROJECT NARRATIVE Reduced drug use and its attendant positive health effects are clinically meaningful targets for treatment development, but few studies have evaluated the positive impacts produced by this behavioral change, preventing adoption of these endpoints in clinical trials. The proposed trial will fill that critical knowledge gap by prospectively demonstrating the biopsychosocial benefits of reduced methamphetamine use. These data will be used to change current accepted treatment endpoints and accelerate identification of therapies for Methamphetamine Use Disorder.